Digestive Disease Training Program

PROJECT SUMMARY
The purpose of the Medical University of South Carolina (MUSC) Digestive Disease Training Program is to train
a cadre of researchers who will drive the future of liver and gastrointestinal (GI)-related biomedical research
within three fundamental thematic areas: 1) Inflammation and Fibrosis; 2) Metabolic Disease; and 3) Organ and
Tissue Failure. These themes are highly-relevant to major disease states affecting the health of the GI tract and
liver and build upon the strengths of our established researchers. The emphasis of the program is to train
graduate students in the art of basic biomedical research in a manner that will advance the study of the
fundamental mechanisms underlying digestive and liver disease. Success will expand the pool of qualified
digestive disease researchers and facilitate the development of novel treatments. Trainees will be selected from
a pool of applicants that enter the MUSC College of Graduate Studies. After completing a basic biomedical
sciences curriculum during their first year in as graduate students, trainees appointed to the Digestive Disease
Training Program will take newly-developed courses that focus on digestive disease research and that
complement their dissertation research projects. In addition, they will have access to courses offering instruction
in professional development, experimental design and analyses, and rigorous, responsible conduct of research.
Students’ coursework will be complemented with a number of enrichment activities including a Digestive Disease
Seminar Series, a Journal Club, an Annual Digestive Disease Retreat, and numerous career development
opportunities. The program will be supported by a growth in digestive disease research at MUSC that is driven
by strategic institutional investments, programmatic support, and the recruitment of key faculty. MUSC’s robust
clinical environment, commitment to diversity, and investments in numerous research cores will continue to
advance digestive disease research on campus and provide trainees with a robust and scholarly training
environment.

Public health relevance
PROJECT NARRATIVE The Medical University of South Carolina (MUSC) Digestive Disease Training Program will train a cadre of predoctoral researchers who will drive the future of liver and gastrointestinal (GI)-related biomedical research within three fundamental thematic areas: 1) Inflammation and Fibrosis; 2) Metabolic Disease; and 3) Organ and Tissue Failure.